Testing a Mechanistic Model of Attention to Social Media Content and Sleep Disturbance in the Escalation of Social Anxiety in Adolescents

Project Summary
This R01 project proposes to test a developmentally informed, mechanistic model of the relations between
social media (SoMe) use and social anxiety symptoms (SA) in adolescence, examining attention perturbations
and sleep as key variables that impact risk. There is a steep increase in both SoMe use and SA in
adolescence. Although total self-reported time spent using SoMe has been associated with SA in adolescence,
findings are mixed and the literature suffers from well-documented assessment and design limitations.
Consequently, “little is known about the mechanisms by which SoMe use may impact risk” (RFA-MH-23-115).
There is a critical need for longitudinal research using sophisticated approaches to assess SoMe use and test
a mechanistic model of its influence on SA in adolescents. This project responds directly to that need.
Guided by developmental cognitive neuroscience, our model posits perturbed attention to social content
and key features of sleep disturbance (poor perceived sleep quality and poor sleep efficiency) as central
variables on the path from SoMe use to SA. Attention acts as a gatekeeper through which social information is
selected for processing, thus shaping how adolescents experience their social world. Exciting data from
members of our team document that perturbed attention to social content is related to higher levels of SA and
sleep disturbance. Additional data document that SoMe use, especially at bedtime, is related to sleep
disturbance and sleep disturbance is related to SA in adolescence. Hispanic/Latine adolescents are particularly
impacted, as they experience anxiety and sleep disturbance at higher rates and are more likely to report using
SoMe “almost constantly,” compared with other ethnic groups.
Together, these data position us to provide the first test of a developmentally informed, mechanistic model
wherein: bedtime SoMe use predicts SA and sleep disturbance (Aim 1) -- when adolescents show perturbed
attention to social content (i.e., moderation) (Aim 2) -- and sleep disturbance mediates the relationship
between SoMe use and SA (Aim 3). We will test this model in 252 biologically male/female, predominately
(75%) Hispanic/Latine adolescents ages 13-17 years, using an accelerated longitudinal design, assessing
adolescents four times over 18 months. Addressing assessment limitations that characterize prior work, we will
use passive sensing and ecological momentary assessment to characterize the timing, location, and behaviors
of SoMe use; established eye-tracking paradigms to measure attention to social content; and subjective (daily
diary) and objective (actigraphy) methods to measure sleep disturbance.
This project will provide a rigorous test of a mechanistic model of the escalation of SA in adolescents. It
also will identify modifiable targets (features of SoMe use, sleep, and attention) that we would pursue in future
projects to prevent the escalation of social anxiety symptom severity in adolescence.

Public health relevance
Project Narrative There is a critical need to identify etiological mechanisms implicated in social anxiety to inform prevention efforts and guide treatment development. This R01 addresses this need by testing a mechanistic model of the relationship between social media use and social anxiety in adolescents ages 13 to 17 years, focusing on attention perturbations and key features of sleep disturbance as variables that impact risk. Findings of the proposed research are expected to identify modifiable targets that can be leveraged to prevent the escalation of social anxiety severity in the key developmental period of adolescence.